The Historically Black Colleges/Universities and Communities Worker Health and Safety Training Program

Project Summary/Abstract
The Deep South Center for Environmental Justice, Inc. Hazardous Waste Worker Training Center
provides training to hazardous materials and wastes workers who may perform jobs covered by the
Occupational Safety and Health Administration's (OSHA) Hazardous Waste Operations and Emergency
Response (HAZWOPER) standards and assist employers in complying with OSHA standard 29 CFR
1910.120. The Consortium's goal is unique as its emphasis is on underserved populations in its
Hazardous Waste Worker Training Program (HWWTP) and Environmental Careers Worker Training
Program (ECWTP); and populations critical to post-disaster recovery in its Hazmat Disaster Preparedness
Training Program (HDPTP).
The proposed HWWTP is designed to provide model occupational safety and health training for
workers who are or may be engaged in activities related to hazardous waste removal, containment or
chemical response. The emphasis is on servicing workers of entities where health and safety training are
critical to the worker’s wellbeing. These workers include emergency responders and small
municipality city workers and or cities where budgeting restraints or working conditions, greatly reduces
or eliminates the possibility of training. Volunteer fire departments and small county police forces, city
health department employees, port authority workers, mosquito control employees, HBCUs, small
minority and disadvantaged businesses are workers the Consortium has trained.